Multi-site DBS with precise timing control focusing on synaptic plasticity

PROJECT SUMMARY
Deep Brain Stimulation (DBS) is a prevalent therapy approved by the U.S. Food and Drug Administration that
uses electrical stimulation of brain nuclei to treat the symptoms associated with movement disorders. However,
a lack of immediate feedback to determine its efficacy for treating other disorders has led to suboptimal
therapeutic effects. Thus, re-imagining DBS may lead to more effective therapies that treat the root cause of the
disorder, and not just address its symptoms. These therapies may require exploring innovative approaches that
leverage our understanding of neural plasticity mechanisms.
Spike-timing dependent plasticity (STDP) is a well characterized phenomenon that can induce neuroplasticity
via phase-locked activation of pre- and post-synaptic neural elements. Here, we propose a novel approach that
combines STDP and DBS (STDP-DBS) and is capable of selectively changing maladaptive plasticity associated
with pathologic neural activity and behavior observed across multiple neurologic and psychiatric disorders,
including alcohol addiction.
In this proposal, STDP-DBS applied with precise timing at two regions of the brain such as the Globus Pallidus
internus (GPi) and the Anterior Cingulate Cortex (ACC) will enable selective bidirectional gain control of cortico-
striato-pallidal signaling. In turn, this will allow control of maladaptive neural signaling that contributes to the
pathology of neurologic disease while avoiding off-target disruption of non-pathological brain activity, in turn
minimizing potential side effects of conventional DBS.
The work proposed here represents the first steps toward correcting maladaptive plasticity associated with
neurologic and psychiatric disorders. In turn, this may enable a new avenue for treatment of a wide range of
disorders such as addiction, Tourette’s syndrome, obsessive compulsive disorder, schizophrenia, Parkinson’s
disease, major depressive disorder, and many others.

Public health relevance
PROJECT NARRATIVE This proposal seeks to correct maladaptive pathological imbalances in neural activity associated with neurologic and psychiatric disorders, including chronic alcohol consumption, by using a novel approach that allows targeted and selective changes in synaptic plasticity, surpassing the limitations of commonly used pharmacologic and electrical stimulation interventions. The work proposed here has the potential to treat the pathology underlying many neurologic and psychiatric disorders rather than treating only the symptoms. In turn, this work may enable the development of new treatments for a wide range of neurologic and psychiatric disorders such as Addiction, Tourette’s syndrome, Obsessive Compulsive Disorder, Schizophrenia, Parkinson’s disease, Major Depressive Disorder, and many others.